Development and Evaluation of a Culturally Grounded, Empowerment Self Defense Program for Adult Women Survivors of Sexual Violence

Project Summary
American Indian/Alaska Native (AI/AN) women experience disproportionately high rates of sexual violence
(SV) and subsequent symptoms of depression and posttraumatic stress disorder (PTSD) as well as related
issues such as suicidality, problem drinking, sexual revictimization, and intimate partner violence (IPV). We
know little about how to address mental health problems related to SV in AI/AN women, particularly those living
in rural/remote tribal communities where access to quality care is limited or non-existent. Current best practices
for AI/AN populations suggest that existing empirically supported treatments for mental health concerns have
limited applicability and stress the need to develop and test culturally adapted interventions. The current
proposal supports a culturally grounded mental health initiative that centers AI/AN voices, leverages the power
of connection to others, and moves away from individualistic interventions. More specifically, the purpose of
this study is to culturally adapt and evaluate an empowerment self-defense (ESD) program (i.e., IMpower) for
AI/AN women who have experienced SV in their lifetime and currently experiencing moderate to severe levels
of depression and/or PTSD symptoms (primary outcomes). Previous research with non-AI/AN women finds
that ESD reduces depression and PTSD symptoms, but no research has examined ESD among AI/AN
survivors despite calls from our tribal partners to implement ESD with AI/AN adult women survivors. We have
assembled an interdisciplinary expert team and Elders/Traditional Knowledge Keepers (TKKs) as well as
Survivor Advisory Board (SAB) in the proposed work. Aim 1 (Adaptation) includes using an Indigenized
ADAPT-ITT Model to refine IMpower into an Indigenized ESD for survivors (IMpower-Survivors) via ongoing
feedback from the Topical Experts/TKKs and the SAB (Aim 1a), theatre testing IMpower-Survivors (Aim 1b),
and an open pilot trial of the IMpower-Survivors with 12 AI/AN women survivors to further refine and evaluate
the feasibility of the program and research procedures (Aim 1c). Aim 2 (Evaluation) will include a pilot RCT of
100 AI/AN women who have experienced SV and have elevated PTSD and/or depressive symptoms randomly
assigned to the treatment or wait list control condition. We will assess the acceptability and feasibility of the
IMpower-Survivors (Aim 2a) via program observations, post-session surveys, and exit interviews with AI/AN
women who have survived SV. We will test the hypotheses that IMpower-Survivors will lead to changes in
intervention targets (reduced fear of future SV, reduced self-blame, increased empowerment, increased social
support, and increased cultural identity) compared to the wait-list control condition (Aim 2b). We will also
examine the hypotheses that there will be reductions in symptoms of depression and PTSD (primary
outcomes; Aim 2c) and suicidality, problem drinking, exposure to IPV, and sexual revictimization (secondary
outcomes; Aim 2d) among AI/AN women survivors in the treatment condition compared to control.

Public health relevance
Project Narrative Although research documents the concerning rates of sexual violence against American Indian/Alaska Native (AI/AN) women and subsequent mental and behavioral health problems (e.g., symptoms of depression and PTSD, suicidality, problem drinking) there is very little known about how to address these deleterious outcomes that devastate AI/AN communities. The proposed project aims to adapt and evaluate an empowerment self-defense program to ameliorate mental health and related problems among AI/AN women who have experienced sexual violence. The proposed project aligns Goal 3 of the NIMH to identify targets for intervention via a rigorous pilot RCT with a highly marginalized and underserved population.